NINDS Human Cell and Data Repository (U24)

Abstract The NINDS Cell and Human Data Repository (NHCDR), housed at Infinity BiologiX distributes source cells and iPSC to academic and for-profit researchers worldwide. The focus of this repository is to provide the global scientific community with the highest quality cell lines for models of human development and disease progression and for drug screening and toxicology. The NHCDR website serves as the portal for both requesting cells lines and for housing data related to them. This application is to support whole genome sequencing and mRNA-seq of iPSC generated from subjects with Frontotemporal Dementia or Lewy Body Dementia and the dissemination of the resulting data through the NHCDR website. This data will also be used to better understand genomic changes that can occur during the generation of iPSC and the transcriptomic differences between independent iPSC isolates from a single reprogramming.

Public health relevance
Project Narrative The NINDS Human Cell and Data Repository distributes a wide range of cell lines from subjects affected with neurological disorders such as Lewy Body Dementia and Frontotemporal Disorder that can be used in disease modeling, drug discovery and toxicological testing. The use of the latest sequencing technologies to better understand the genetics behind these diseases will allow for the development of new treatments and strategies to better combat these diseases.